Genomic resources and references for genetic investigation of an understudied population

Project Summary
The benefit of genome-wide association studies (GWAS) unfortunately has limited transferability to less
studied minority populations. Participants of GWAS are typically of European descent and transferability of
genomic insights gained from GWAS is dependent on how closely related the populations are in either history
or characteristics. As a result, there exists a growing disparity when it comes to the understanding of disease
incidence and genetic risk factors for non-European populations. There are also factors that impede the study
of minority populations including limited cohort size, the lack of genomic resources, and admixture history and
population structure that may complicate the study design and analysis. However, focused studies of minority
populations, even with smaller sample sizes, have been shown to provide population-specific genetic insights.
The goals of this proposal are (1) to generate genomic resources for the Native Hawaiian minority population
necessary for accurate and systematic analyses, and (2) to leverage these resources and the unique
population history of Native Hawaiians to identify genetic risk factors associated with complex traits. These
goals will help reduce the barriers to current and future studies of Native Hawaiians and also reduce the gap in
our understanding of health in their population. In order to accomplish this, Aim 1 and Aim 2 focus on creating
an imputation reference panel and recombination map specific to the Native Hawaiians, respectively. An
imputation reference panel specific to a population has been shown to increase genotype imputation quality of
both common and rare variants that would not otherwise be included in a genetic study. A recombination map
is a critical resource that is utilized in haplotype-based inference (such as local ancestry inference or identity-
by-descent segment detection), which is critical for admixed populations such as the Native Hawaiians. Lastly,
in Aim 3, we will use these resources and exploit the population history of the Native Hawaiians to identify
genomic regions associated with complex traits. We will leverage the expected increase in deleterious alleles
found in homozygous state and use identity-by-descent mapping to identify regions associated with diseases
previously shown to have elevated risks in Native Hawaiians (obesity, type-2 diabetes, or cardiovascular
diseases). In summary, this work will provide genomic resources specific to the Native Hawaiians and related
populations, but also explore the relationship between traits and disease that may impact all populations.

Public health relevance
Project Narrative Although genome-wide association studies have been predominantly focused on European populations in recent years, understudied populations such as the Native Hawaiians may provide genetic insights due to their unique population history and different disease incidence rates. The proposed research will provide genomic resources specific to the Native Hawaiian community to enable systematic genetic analysis in this population and reduce the barriers of future studies in other related populations.